Exploring Dopamine Transporter Recycling and Trafficking Defects in Parkinson's Disease

PROJECT SUMMARY
Parkinson's Disease (PD) is characterized by the progressive loss of dopaminergic (DA) neurons within the
substantia nigra (SN), resulting in debilitating motor impairments. To develop therapeutic interventions that can
be administered prior to extensive DA neuron loss, early pathomechanisms at the DA synapse must be explored.
Central to PD pathology is the dysregulation of dopamine neurotransmission, which is in part mediated by the
dopamine transporter (DAT). Interestingly, DAT surface levels are controlled by the endolysosomal system,
which includes several proteins mutated in familial and sporadic PD. For example, loss-of-function (LOF)
mutations in the clathrin uncoating chaperone, auxilin, cause early-onset PD, whereas the D620N mutation in
VPS35, a retromer protein, causes familial PD that is phenotypically similar to sporadic PD. My lab's study of
auxilin knockout (KO) mice suggests that disruptions in DAT function and trafficking precede DA
neurodegeneration, which is further supported by changes in DAT expression and function in VPS35 D620N
knockin (KI) mice. Determining whether DAT dynamics are impaired across genetic etiologies of PD will be
pivotal to the field's understanding of early PD pathology and DA vulnerability. This study will test the hypothesis
that DAT recycling and trafficking defects occur in forms of PD involving endolysosomal mutations by using
cutting-edge live and super-resolution imaging techniques and in vitro PD models. To measure DAT endo- and
exocytosis with high temporal resolution in Aim 1, I developed a DAT-pHluorin that I will express in primary SN
DA neurons from auxilin KO and VPS35 D620N KI mice. To account for species differences, I will also validate
my results in induced pluripotent stem cell (iPSC)-derived DA neurons from PD patients with auxilin LOF and
VPS35 D620N mutation. I hypothesize that auxilin PD models will display delayed DAT vesicle reacidification
after endocytosis, and both auxilin and VPS35 PD models will exhibit reduced magnitudes and rates of DAT
reinsertion following endocytosis, signifying impaired DAT recycling, due to distinct mechanisms. To further
explore these mechanisms, Aim 2 will utilize DAT-PRIME imaging, which fluorescently labels surface DAT in live
cells, to track DAT post-endocytic fate in the aforementioned models. Using stimulated emission depletion
microscopy paired with immunofluorescence staining, I will assess the colocalization of DAT with various
endolysosomal markers to understand the role of auxilin and VPS35 in controlling post-endocytic fate of DAT. I
predict that loss of clathrin uncoating by auxilin will stall DAT trafficking at the early endosome stage, leading to
reduced DAT trafficking to recycling endosomes and retromer compartments. On the other hand, VPS35 D620N
neurons are likely to show enhanced lysosomal trafficking of DAT due to retromer LOF. This study will shed light
on mechanisms underlying early DA dysfunction in PD and provides me with the opportunity to further my
scientific training through mentorship by experts in synaptic biology, neuronal cell culture, and microscopy.

Public health relevance
PROJECT NARRATIVE Studying early pathological occurrences at dopaminergic synapses may reveal key insight into mechanisms of dopaminergic neuron vulnerability in Parkinson's Disease (PD). This project will utilize live imaging and super-resolution microscopy in primary dopaminergic neurons and induced pluripotent stem cell-derived dopaminergic neurons from PD patients to explore whether defects in dopamine transporter (DAT) recycling and trafficking occur in genetic forms of PD with mutations in endolysosomal proteins. This work will further the field's understanding of early dopaminergic pathology in PD and help identify targets for presymptomatic, disease-modifying therapeutic interventions.